Usable Electrical Impedance Tomography for Children in the ICU

Abstract / Project Summary
The aim of this project is to develop a design for a modern Electrical Impedance Tomography
(EIT) device to monitor children in the Intensive Care Unit. Our approach to building this new
technology is to follow a rigorous ideation, prototyping and testing process as we aim to
advance a novel design into the clinic. Our aims are to (1) generate initial designs for an
advanced lightweight EIT belt and (2) assess technical feasibility of a miniaturized, easier to use
EIT core device. The project is a collaboration between engineers and clinicians in order to
generate a usable form of EIT that can be implemented in daily use. If successful, these
inventions will be used to monitor half of the 5,000,000 patients per year in the US that are
admitted to the Intensive Care Unit, and to diagnose many hundreds of millions more who have
trouble with COPD, sleep apnea and a host of other respiratory conditions at home and in the
hospital. Neonates are particularly sensitive to changes in ventilation and there simply are no
other tools that can deliver assessment of regional venilation in the NICU.

Public health relevance
Project Narrative We aim to develop an novel application of a 40 year old technology for assessing ventilation in patients. We are building this new technology through a rigorous prototyping and testing process as we aim to advance a novel design into the clinic for daily use, where today it is relegated to research. This invention will be used to guide treatment of the the 5,000,000 patients per year in the US that are admitted to the Intensive Care Unit, the children that are born with pulmonary dysfunction and may have application for the many hundreds of millions more who have trouble with COPD, sleep apnea and a host of other respiratory conditions at home and in the hospital. With this we will be able to address FDA concerns about safety and make the technology available for infants in the NICU younger than 28 days.